Genome-wide profiling of histone variants in Drosophila and Caenorhabditis

Speed up data submission with partial support of a starting computational engineering postdoctoral fellow who will be dedicated to our project.

Public health relevance
Cancer and many other human diseases are both genetic and epigenetic, and a large body of work has implicated chromatin-based processes as being largely responsible for the epigenetic component. Our development and application of a new tool for chromatin profiling in modENCODE model organisms was a necessary first step in applying these methods to human material as represented by the ENCODE project. Furthermore, what we expect to learn from human genome-wide mapping using the novel tools that we have developed is expected to provide a physical basis for the delineation of chromatin properties and epigenetic marks.